Nanopore-based sequencing of placenta-cell-type-specific extracellular RNA for real time assessment of human placenta development and function

Circulating placenta-derived extracellular RNAs (exRNAs) offer tremendous potential as safe, highly-informative,
non-invasive biomarkers for placental function because they provide dynamic data regarding the functional,
metabolic, inflammatory and perfusion state of the placenta and reflect the status of the placenta at a cellular
level beginning in the first trimester. Thus, they can reflect problems before structural or end-organ effects have
occurred and thereby enable risk-stratification, early intervention, and provide valuable insights into disease
pathogenesis. However, widespread clinical application of exRNAs as biomarkers for placenta function
has been limited by numerous technical limitations: (1) Existing exRNA isolation kits/protocols have poor
recovery rates, size biases, do not inactivate the ubiquitous nucleases sufficiently to preserve the information-
rich long coding transcripts, and are too costly and not amenable to automated application that would be required
in a clinical setting, (2) placenta-derived exRNAs represent only a fraction of total exRNAs and hence sequencing
depth has to be very deep in order for them to be adequately sampled, (3) the full repertoire of placental cell
types and characteristic transcripts were not known and thus could not be fully queried and, (4) existing
sequencing technologies have library preparation and sequencing times that are too long to permit turn-around-
times with sufficient speed to provide results in a timely and actionable manner. In this grant, we assemble a
multidisciplinary and multi-institutional team to develop four innovative new technologies that we
pioneered that, when combined and optimized, offer an opportunity to solve these limitations and make
exRNA a transformative clinical and research tool. In Aim 1, we use Automated exRNA isolation (AxRI), a
novel method for automated, high-throughput, low cost, isolation of exRNA with near-instantaneous inactivation
of nucleases and consequent protection of the information-rich coding RNA transcripts to isolate exRNAs from
maternal circulation. We then use a customized capture assay, adapted from one we developed for cancer panel
screening, to enrich placenta-derived transcripts using transcript information from our single-cell atlas of the
human placenta. In Aim 2, we further develop our nanopore-based library preparation and sequencing
technology to sequence the transcripts on a hand-held, disposable nanopore-based DNA sequencer at speeds
that are much faster than existing next-generation technologies and that can deliver same-day results. In Aim 3,
we apply the technologies developed in Aims 1 and 2 to generate and validate reference profiles for exRNA
transcripts across gestation beginning in the early first trimester. Collectively, the development, optimization,
validation, and combination of the technologies proposed in this grant will result in a clinically-viable
and affordable platform that will provide an unprecedented ability to safely and non-invasively assess
placenta function and composition at a near-cellular level and transform how we monitor and study
pregnancy.

Public health relevance
In order to have a healthy pregnancy, the placenta must function normally; problems with how the placenta functions can result in severe illness for the mother and baby including conditions such as preeclampsia, problems with fetal growth and even preterm birth and stillbirth. In this proposal we bring together three research groups that have each pioneered new technologies which, when combined, will give obstetricians and researchers the ability to safely monitor, in real-time, how the placenta is functioning by measuring RNA molecules that are released from the placenta and into the mother’s circulation. This project will result in new ways to detecting problems with the placenta very early in the pregnancy on so that physicians and researchers can learn what causes pregnancy complications and how to prevent them before any harm occurs to the mother or baby.